NCI'S GENOMIC CHARACTERIZATION CENTER IDIQ

The Broad Institute will continue to build on our 30 year track record as a Genome Center and apply a suite of well-validated platforms and advanced analytic tools to comprehensively characterize genomic alterations of cancer specimens. For this Task Order, we will characterize up to 3650 samples (with optional quantities of up to 2650 additional samples). We will apply whole exome, whole genome, methylation arrays, and deep custom sequencing to identify somatic alterations from both fresh frozen and FFPE specimens and have documented extensive experience with these types of analytes. Specific activities will include: (1) receiving, qualifying and fingerprinting 3650 samples (with optional
quantities of up to 2650 additional samples). (2) performing sample prep and sequencing at a scale (3) performing QC of resulting sequence data to ensure correct sample identity and suitable data quality for downstream analysis; (4) depositing data into the public domain in a timely and accessible format to allow broad access and usage of the sequence data.